CRISPR-Cas9 base editing approaches to discover ubiquitination events promoting flavivirus infection

PROJECT SUMMARY
Viruses extensively remodel the cells that they infect. Ubiquitination networks are frequent targets of viral
manipulation, but compared to other modifications such as phosphorylation, our general understanding of
functional ubiquitination events is limited. In this project, we will apply CRISPR-Cas9 base-editing approaches
to assess ubiquitination site function in a systematic, unbiased manner in the context of flavivirus infection. We
have previously quantified ubiquitination responses to West Nile virus (WNV) infection, identifying hundreds of
modulated ubiquitination targets with unknown functions. In Specific Aim 1, we will systematically introduce
mutations at these ubiquitinated residues and assess the impact on WNV infection in a pooled base-editing
screening format. In Specific Aim 2, we will apply base editing to perturb ubiquitination enzyme active sites for
enzymes that physically interact with flavivirus NS5 proteins. Successful completion of these aims will discover
novel pathways that promote flavivirus infection and will provide CRISPR-Cas9 base-editing resources tailored
towards research questions in virology and ubiqutination functions.

Public health relevance
PROJECT NARRATIVE Ubiquitination is a prominent type of protein modification that can alter protein functions. Modern approaches can measure tens of thousands of ubiquitination events, but it is difficult to determine which of those are biologically meaningful. This project will develop new genome-editing approaches to better understand the functions of ubiquitination events in the context of WNV infection, which can help better understand the pathways required by the virus for replication and potential weaknesses that can be exploited for therapeutic development.